Administrative Core

Administrative Core Summary
The primary purpose of the administrative core is to provide sound management of the
INBRE-award, on behalf of the network. In addition, this core will provide leadership and
direction to enable the network to grow in a purposeful and managed way. The
administrative core will provide leadership and oversight of the bioinformatics and
research cores, as well as, all other activities, adjusting and balancing the commitments
and needs of each, such that the overall network is productive and impactful. The core
will be responsible for tracking and evaluation of all network activities, including mentoring
and training.